Regulation of the lens transcriptome and chromatin architecture by FOXE3

Revelation of novel molecular mechanisms that regulate transcriptional networks controlling cellular
differentiation provides essential information relevant both to understanding organogenesis and for
reprogramming cells for regenerative therapies. The ocular lens provides a simple, self-contained tissue with
characteristic patterns of differentiation-specific gene expression to model how transcription factors regulate
chromatin landscapes to direct specific transcriptional networks through cooperative interactions with enhancers,
promoters, and other regulatory protein complexes. The forkhead transcription factor, FOXE3, is an abundant
transcription factor expressed in the early lens forming ectoderm, and maintained in the lens epithelium,
downstream of PAX6 expression. In fact, mutations in FOXE3 mirror many of the ocular phenotypes (Peters
anomaly, cataracts, reduced epithelia proliferation and fiber cell differentiation) resulting from deficiencies in
PAX6 or AP-2, the two other abundantly expressed transcription factors in lens epithelium. However, little
information exists concerning how FOXE3 regulates lens development. An RNA-seq analysis in lenses from a
newly created Foxe3 allele identified numerous differentially regulated genes. These included downregulation of
many classical lens identity genes (including Bfsp1, Bfsp2, Dnase2b and multiple crystallins) and upregulation
of many genes associated with neural and or retina differentiation (including Nr2e1, Otx2, Ascl1, Tbx3, Rax,
Vsx2, Lhx2 and Six6). This surprising shift in gene expression in FOXE3 deficient lenses, coupled with the
structural similarity of FOXE3 to several pioneer transcription factors that can act as key drivers of cellular
differentiation and reprogramming, led to the hypothesis that transcriptional regulation of gene expression
in lens mediated by FOXE3 is determined by its dynamic interactions with chromatin resulting in its
presence in both open and closed chromatin through cluster of adjacent cis-regulatory sites and trans-
acting DNA-binding transcription factors in the promoters and enhancers. Two specific aims will test this
hypothesis. 1) To determine how the loss of FOXE3 function affects chromatin landscape and gene control in
the lens, combinations of ATAC-seq, scRNA-seq and bulk RNA-seq will be employed on Foxe3 null lenses. 2)
To determine the cis-regulatory grammar of FOXE3-bound promoters and enhancers in lens, FOXE3 binding
sites in lens chromatin will be discovered using CUT&RUN followed by bioinformatic analysis to identify the
consensus FOXE3 binding motif and adjacent transcription factor binding motifs. This information will be
integrated to discover direct FOXE3 transcriptional targets, which will be validated by RT-qPCR and luciferase
assays. The fundamental information gained by these approaches will fuel broader and systematic analysis of
molecular mechanisms of gene control by FOX transcription factors focused on their impact on chromatin
structural dynamics for tissue differentiation and cellular reprogramming.

Public health relevance
The proposed research is relevant to public health because a molecular understanding of how transcription factors function cooperatively to regulate genomic epigenetic landscapes lies at the heart of curative and regenerative disease therapies. The ocular lens, with its uniquely simple, isolated architecture and stereotypical patterns of continuous growth and differentiation provides a powerful model system to uncover the fundamental rules of transcriptional control that govern development, structure and function of diverse tissues and organs. The proposed research is relevant to the NIH’s mission because mutations in FOXE3 cause a wide variety of ocular abnormalities yet the mechanism(s) by which FOXE3 controls gene expression remain(s) almost entirely unknown.